Rodent Cancer Models Core

The Rodent Cancer Models Shared Resource (RCM) provides Duke Cancer Institute (DCI) members a full
service approach to the investigation of cancer biology, from the creation of rodent models through the
testing of chemotherapeutics. To achieve that goal DCI’s RCM combined two primary services: the Cancer
Center Isolation Facility (CCIF) and the Rodent Genetic Engineering Services Team (RGEST). CCIF is a
30,000 square foot, stand-alone rodent barrier facility located in the heart of the Duke biomedical campus
operated by the Duke Division of Laboratory Animal Resources (DLAR) and dedicated to cancer research.
The CCIF physical plant supports work with hazardous materials at biosafety level 2 (BSL2), recombinant
DNA, chemotherapeutics, as well as the maintenance of immunosuppressed (outbred athymic nude mice
and inbred Nod SCID gamma (NSG) mice) and specific pathogen-free (SPF) rodents. Occupying space in
CCIF and in nearby facities, RGEST produces custom designed, genetically altered, transgenic and gene-
targeted mice. RCM personnel assist DCI investigators who require assistance with breeding services,
veterinary or diagnostic services, animal and experimental protocol development, inoculation or testing of
cell lines, and guidance for conducting safe and efficient cancer biology research. CCIF also provides
equipment and rodent housing space for the CCSG-supported Optical Molecular Imaging and Analysis
(OMIA) shared resource. Recently, significant investments by the Duke School of Medicine have enabled
upgrades to CCIF and RGEST equipment.
In 2022, the RCM provided services to 67 DCI investigators, 71% of all users and representing 6 of the DCI
Research Programs. Use of this shared resource by DCI Members contributed to 142 DCI publications over
the project period, 50 of which were in high impact journals (Impact Factor>10), demonstrating the value of
RCM services. The immediate and long-term objectives of the RCM are to continue to provide high-quality
barrier facility services, low-cost, high-quality immunocompromised and SPF mice and genetically
engineered animal models using cutting edge approaches, improve and upgrade services when possible,
and to provide key expertise and services to DCI members studying cancer biology and developing new
agents for treating or diagnosing human cancers.